Neutrophil Bioenergetic Metabolism in Sepsis

PROJECT DESCRIPTION: The goal of this Administrative Supplement application is to support the purchase
of the Agilent Technologies Seahorse XF Pro metabolic analyzer (XF Pro) to determine neutrophil bioenergetic
metabolism in sepsis, which is highly relevant to the parent grant R35GM118337 entitled "Novel Approaches to
Maintaining Organ Function in Sepsis". Sepsis affects at least 1.7 million Americans annually, causing the
death of 270,000 patients and being responsible for 30% of all hospital deaths. Unfortunately, there are
currently no specific effective therapies for septic patients. We discovered that extracellular cold-inducible
RNA-binding protein (eCIRP) expands a novel and damaging neutrophil population, which we named antigen-
presenting aged neutrophils (APANs), thus markedly increasing organ injury and death in sepsis. eCIRP has
been shown to cause changes in mitochondrial biogenesis and mitochondrial DNA fragmentation. However,
even though cellular energy metabolism and mitochondrial biogenesis play a critical role in the immune
response, the effects of eCIRP-induced changes in mitochondrial bioenergetic metabolism on the induction,
activation, and function of APANs have never been studied. The XF Pro is a high-throughput, top-of-the-line
metabolic analyzer that assesses and allows the manipulation of mitochondrial respiration, glycolysis, and ATP
production rate of live cells in real-time. Our proposed mitochondrial studies with the XF Pro will significantly
expand the scope of the parent MIRA award by interrogating three new questions related to those already
being investigated in the parent R35 award: 1) What is the role of metabolic reprogramming in eCIRP-induced
APAN expansion? 2) What is the role of metabolic reprogramming on APANs’ aggravation of sepsis? 3) Does
targeting eCIRP mitigate sepsis via suppression of metabolic reprogramming? In summary, the XF Pro will
enable experiments to significantly expand the current understanding of the underlying pathogenetic
mechanisms, discover and evaluate novel potential therapeutic targets, and assess promising novel treatments
for septic patients.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT: Sepsis is a common and deadly syndrome that still lacks specific treatment other than antibiotics and intensive care. By purchasing a high-throughput, top-of-the-line metabolic analyzer, we will be able to assess and manipulate the bioenergetic status of live cells in real time. With these experiments, we expect to significantly expand the current understanding of how organ injury develops in sepsis and explore new ways to treat septic patients.